Recovery Finance: Financial health and mental health after incarceration

Program Summary/Abstract
People who experience incarceration and have mental health challenges are disproportionately Black and
Latinx, and low-income. This group experiences financial hardships regardless of incarceration due to racism
and other forms of discriminations, with associated negative health outcomes. These financial issues have a
direct impact on health, create barriers to employment and housing, stress social networks, contribute to
feelings of exclusion and contribute to recidivism, all of which are health determinants. The goal of the parent
award is to intervene at the community level to reduce financial difficulties of individuals with incarceration
histories and mental health challenges, who are predominantly Black and Latinx.
The proposed diversity supplement investigates how employment experiences shape financial behaviors and
psychological well-being post-incarceration. Using mixed methods with justice-involved individuals in New
Haven, it examines how pre-incarceration job conditions influence current financial attitudes and knowledge.
In-depth interviews explore connections between early vocational exposures and present economic situations
and psychological wellness. Concurrently, contemporary workplace contexts are tracked longitudinally,
assessing barriers and facilitators impacting financial stability during reentry. Integrated analysis clarifies how
formative work experiences necessitate tailored financial empowerment initiatives responsive to situated
transitional realities. Elucidating these complex interrelationships addresses major scholarly gaps while
generating actionable evidence to foster supportive labor market climates. Core ethical commitments center
participatory design, upholding collaborative interpretation, and methodology justice principles. This project's
focus on employment's instrumental role in capability development. Justice-involved individuals help
development through this stakeholder partnership. Findings will delineate structural reforms plus the
development of a tailored intervention that promotes equitable inclusion and multidimensional flourishing.

Public health relevance
ProjectNarrative- Parent Award This innovative proposal will address financial wellbeing, an often overlooked but important factor impacting reentry for justice-involved people with mental health challenges, who are disproportionately Black and Latinx. This project will change community level determinants by integrating financial capability supports (one-on-one coaching and access to financial tools and services) into existing services, and training bank and credit union staff to reduce discrimination. It will also support collaborative community efforts working towards upstream policy and legal reforms to reduce the incidence of those financial challenges.